A Comparative Study of Medical Examiner/Coroner Offices in the United States

Project Summary/Abstract
Native, Black, and Latinx people are disproportionately killed during police encounters
and these murders are rarely prosecuted. Much of the social justice-driven research on
police violence has focused on legal and political interventions that govern law
enforcement practices. This project takes a different approach by examining the science
of the autopsy, the American medical examiner/coroner system, and the nation’s long
legacy of policing and state-sanctioned violence against communities of color. The
medical examiner/coroner system in the United States plays an integral, but often
overlooked, role in determining whether police are held accountable for deaths that
occur under their custody. However, medical examiner/coroner reports rarely establish
police culpability even when evidence indicates otherwise. This project undertakes
archival research informed by media and federal government data on nationwide death
under police custody to recover and document the history of three medical
examiner/coroner offices that have played pivotal roles during the periods of English
settler colonialism, the westward expansion of American empire, and racial segregation
following the Great Migration of Black communities to Northern cities. To this end, the
project will request and analyze images, documents, microfilm, and other materials from
the medical examiner office in Jamestown, Virginia, the country’s first medical examiner
office founded during the era of colonial settlement. This project will also study the Los
Angeles Medical Examiner Office founded after the Treaty of Guadalupe Hidalgo (1848)
in the city that is the current incarceration center of the world. Finally, we will study the
history of the Wayne County Medical Examiner in Detroit, Michigan which is the nation’s
most racially segregated city now undergoing rapid gentrification. Through these efforts,
the project seeks to produce a peer-reviewed book monograph, a series of articles for
public audiences, and the development of policy recommendations for reforming the
medical examiner/coroner system. This project intends to offer new insights about the
history of the U.S. medical examiner system and the politics of autopsy science that will
inform the work of public health officials, community activists, lawmakers, and academic
scholars working on tracking mortality from legal intervention and creating social justice
reforms within policing, law enforcement, and incarceration.

Public health relevance
Project Narrative This project investigates how the violent historical legacy of the U.S. medical examiner/coroner system offers insights into why state sanctioned autopsies conducted for people of color killed during police encounters often fail to align with calls for social justice.